MOVE!+UP: Testing a Tailored Weight Management Program for Veterans with PTSD

Project Summary
Background: Post-traumatic stress disorder (PTSD), prevalent among Veterans, puts Veterans at increased
risk for obesity and related conditions. Veterans with PTSD lose less weight in VA’s MOVE! weight
management program, due to PTSD symptoms that interfere with activity and healthy diet. In addition, many
Veterans who receive evidence-based PTSD treatment remain symptomatic. A behavioral weight loss program
that augments standard PTSD care and targets PTSD-related weight loss barriers called MOVE!+UP was
piloted and iteratively refined among 44 overweight Veterans with PTSD. The fully developed MOVE!+UP is
led by a psychologist and a Veteran peer support counselor, who provide complementary expertise. It includes
16 in-person group sessions with 90 minutes of general weight loss support, coupled with Cognitive Behavior
Therapy skills to address PTSD-specific barriers. Each session also includes a 30-minute community walk to
address hypervigilance-based activity barriers and enhance classroom-based learning. Veterans receive two
individual dietician visits, and counseling calls as needed. The cohort receiving the final MOVE!+UP package
reported high satisfaction and had better weight loss outcomes than Veterans with PTSD in the general MOVE!
program. They also reported substantial PTSD symptom reduction. Treatment targets like eating behaviors,
activity, and insomnia also improved. MOVE!+UP effectiveness must be tested in a randomized trial.
Significance/Impact: MOVE!+UP is timely and efficient, simultaneously addressing physical and mental
health of a priority Veteran group. MOVE!+UP is positioned to address HSR&D priorities by promoting mental
health and improving PTSD symptoms, access to care, and whole health. This study is aligned with HSR&D
and ORD methodological priorities by using a hybrid type 1 trial. This study’s cost and utilization analyses, and
systematic identification of implementation barriers and facilitators, would place effectiveness findings in
context and facilitate rapid translation to the field if MOVE!+UP is effective. This study will also provide insights
about ways that general MOVE! and PTSD care can be enhanced to improve reach and effectiveness.
Innovation: MOVE!+UP is the first weight loss program designed to address obesity in Veterans with PTSD.
Specific Aims: This study proposes to randomize overweight/obese Veterans with PTSD enrolled in PTSD
care to usual care enhanced with enrollment in MOVE! (control) or usual care enhanced with MOVE!+UP
(intervention), and is guided by three aims: 1) Test whether intervention participants have greater 6-month
weight loss (primary outcome), and 6-month PTSD symptom reduction and 12-month weight loss (secondary
exploratory outcomes), relative to controls; 2) Assess whether compared to control, intervention participants
have greater improvements on 6-month treatment targets: physical activity, eating behavior, insomnia,
depression, and social support; 3) Estimate intervention and control condition costs and utilization, and identify
MOVE!+UP implementation barriers and facilitators, to contextualize Aim 1 and inform future implementation.
Methodology: Hybrid type 1 trial with 164 overweight/obese Veterans with PTSD enrolled in PTSD care.
Implementation/Next Steps: This hybrid type 1 trial will provide data needed to prepare a MOVE!+UP
implementation package for broader VA implementation if MOVE!+UP is effective. If it is not effective, Aims 2
and 3 will help understand how overweight Veterans with PTSD could be better supported in the future.
Implementation activities would be coordinated with existing local, VISN, and national operational partners.

Public health relevance
Project Narrative Posttraumatic Stress Disorder (PTSD) is common among Veterans and results in poor psychological functioning, quality of life, and physical health. This includes having disproportionately high rates of obesity, in part due to PTSD symptoms interfering with physical activity and healthy diet. Unfortunately, Veterans with PTSD have poorer weight loss outcomes than those without PTSD in VA’s existing weight management program, MOVE!. Based on pilot work, it appears that a weight management program that augments standard PTSD care and targets PTSD-related barriers to weight loss improves weight and PTSD symptoms. Whether it improves these issues more than standard VA care is in need of study, which is the focus of the proposed research. The proposed study also seeks to understand factors that would interfere with and facilitate implementing the program in VA if it is effective. This Veteran-centered, tailored weight loss program may efficiently benefit both physical and mental health of Veterans with PTSD, addressing standard care limitations.